ASSAY AND SOFTWARE DESIGN FOR THE WHO HIV SEROTYPING EFFORT AND THE ACTG

The HIV serotyping effort is the largest effort of its kind mounted by the WHO. The Virus Biology Unit (VBS), LTCB, NCI provided pilot data on a log-reduction assay to assess viral neutralization. User-friendly software, the ID-50 program, running on IBM and Macintosh platforms was improved to permit virologists to calculate infectious-doses 50% (ID-50s) or to assess neutralization. After comparing pilot data from several different assays, the WHO team adopted the viral log-reduction assay as a standard for assessing HIV neutralization. The AIDS Clinical Trial Group also accepted the same assay as a standard. The ID 50 program is now being prepared for general distribution.